Preparation of sequencing libraries for multi-analyte analysis of RNAs

Abstract
Circulating cell-free DNA (cfDNA) are commonly considered promising multi-cancer detection (MCD) biomarkers.
The recently proposed Vanguard Study on MCD should help elucidate the effectiveness and practicality of such
tests going forward. Meanwhile, there is growing evidence that cell-free RNA fragmentomes (RFs), which include
small RNAs and RNA fragments, may become a novel class of liquid biopsy biomarkers providing increased
sensitivity due to RNA fragmentome substantially higher abundancy than cfDNA fragmentome. Also, RFs provide
information about biological function and tissues of origin due to the process of their biogenesis. The sequencing
analysis of diverse pools of RFs could be integrated in multiomic approaches that would further enhance their
diagnostic capabilities for cancers and other diverse pathologies. Conventional kits for sequencing library
preparation are limited to the capture of RFs with 5’-p and 3’-OH ends representing only ~10% of the whole RNA
fragmentome. Although several reported methods can detect all or some hidden RF species, none of them can
detect all and distinguish different RF types. Also, the analysis of RFs by different methods is affected by method-
specific biases. Besides the detection of all RF types, it is essential to enable analysis of different RNA classes
represented by different RF types and find the type(s) that allows detection of cancer with higher sensitivity and
specificity. Currently there are no commercially available kits for sequencing-based, comprehensive RF analysis.
To address these technical shortcomings, we propose a novel approach, RealSeq®-RF, that enables profiling of
both the total RF content and the individual RF types in RNA samples using a core library preparation kit with
upfront enzymatic pretreatment(s) effecting the RNA end types. In Phase I, we developed a RealSeq®-RF
prototype and demonstrated its superior ability to: 1) detect all RFs simultaneously and specifically for individual
RF types; and 2) distinguish between plasma RNA samples from patients with breast cancer and healthy donors
based on analysis of differently expressed type-specific RF content in comparison to benchmark Phospho-Seq
method. In Phase II of this project, we plan: 1) optimize RealSeq-RF’s specificity and extend its capabilities of
detecting RFs and different types and lengths in human plasma; 2) convert the optimized of RealSeq-RF into a
commercially viable protocol and first-in-class kit for research and diagnostic applications; 3) adapt the protocol
for automation with liquid and bead handling workstations to minimize technical variability during isolation of
plasma cfRNA, pretreatments and the sequencing library preparations; 4) develop a robust and user-friendly
bioinformatic pipeline to analyze RealSeq-RF sequencing data and generate easily interpreted data
visualizations in the context of disease; and 5) demonstrate RealSeq-RF technology’s to excel in detection of
statistically significant differences in RFs contents between healthy donors and MCD panel plasma samples. We
expect that RealSeq-RF technology will be widely adopted for research and potentially disruptive diagnostic
applications.

Public health relevance
Project Narrative Cell-free RNA fragmentomes (RFs), which represent potentially superior multi-cancer detection (MCD) biomarkers, could be integrated in multiomic approaches (along with cell-free DNA fragmentome) to further enhance sequencing-based diagnostic of cancers and other diverse pathologies. However, currently available kits for RNA sequencing library preparation are limited to the capture of only ~10% of the whole RNA fragmentome that limits their sensitivity and specificity. The goal of this grant proposal is to develop (the first in this field) method and kit (RealSeq®-RF) providing comprehensive profiling of all RF types with different ends representing different RNA classes for research and diagnostic applications.